Multiscale Framework for Molecular Heterogeneity Analysis

DESCRIPTION (provided by applicant): Genomic profiling has become a routine practice in selecting treatments for many diseases, enabling the classification of patients into categories that associate with improved outcomes for specific treatments. One potential detractor to this approach is the tremendous heterogeneity in tissues used for profiling. Genomic classifications, obtained from a relatively small biopsy, are subject to influence from broad, regional variations in the affected tissue. Heterogeneity on a cellular scale can also obscure the target of treatment, as cells with distinct molecular profiles are homogenized in genomic profiling. Realizing better therapies will depend greatly on the ability to understand molecular heterogeneity within an individual, a challenge that necessitates new approaches to organize, analyze and integrate data from multiple spatial and molecular scales. This proposal describes an informatics framework to characterizing heterogeneity for tissue based studies. The framework will combine imaging informatics with genomics to describe molecular heterogeneity at multiple spatial and molecular scales. The imaging component will leverage a novel quantum dot technology that enables detailed mapping of multiple protein expression pathways within a single sample. Fluorescence in situ hybridization imaging will be used to measure DNA content. Whole-slide digitization will enable computer algorithms to capture molecular profiles of hundreds of millions of cells, calculating quantitative features to describe their expression patterns and DNA content. Biologically meaningful descriptions of each cell will be generated using a novel active machine learning classifier to annotate cells with an ontology describing molecular biology and cell anatomy, enabling slides to be analyzed in a biological context. Cell boundaries, features, and annotations will be integrated through the Pathology Analytic Imaging Standards (PAIS) database to provide support for data mining analysis. Mining methods will be developed to find the enrichment of cellular phenotypes, and to analyze the spatial layout of cells with respect to structures like blood vessels to discover the influence of the tissue microenvironment on key expression pathways in surrounding cells. These tools will be applied to studies of glioblastoma brain tumors, but are relevant for studies of other solid tissue diseases. The scientific study wil use tissues resected in a novel clinical trial that accurately defines the invading tumor margin, bulk and necrosis-rich core. Tissues will be analyzed for gene expression and imaging to generate a paired genomic-imaging profile for each region. Mining the imaging and gene expression profiles of these regions will identify intra-tumoral differences in cellular phenotypes and illustrate the extent of variation in genomic classifications. The paired imaging and gene expression profiles will also be mined to determine relationships between specific expression classes and the imaging observations to illustrate a complete picture of heterogeneity. A project repository will be deployed to disseminate images, analysis pipelines and analytic results. This repository will provide a public resource for brain tumor research and access to open source tools.

Public health relevance
PROJECT NARRATIVE Developing effective treatments for disease requires an understanding of their molecular mechanisms. The software tools created by this research will enable researchers to better identify variations in the mechanisms of disease within an individual, and to develop and apply more effective therapies to improve patient outcomes. __SpecificAimsTextDelimiter__ SPECIFIC AIMS This proposal describes an informatics framework to characterize molecular heterogeneity in tissue based studies of disease. The molecular events that drive disease unfold in a complex microenvironment composed of diverse cells with distinct molecular profiles. The inherent molecular diversity of tissues complicates the process of defining effective druggable targets. Genomic analysis of homogenized tissues obscures much of this diversity, and the results are also subject to remarkable variability depending on the sampling effects of a limited biopsy that represents only a small portion of the total affected tissue. Developing tools to describe and understand molecular heterogeneity will be essential to fully realize the promise of personalized medicine. Microscopy imaging provides a window to this complex environment, enabling measurement of billions of protein expression and genetic events at cellular resolution using 200- 400X magnification whole-slide imaging. Pathology whole slide images (WSIs) contain a wealth of information but remain under-utilized in disease research, largely due to unmet informatics needs. The proposed informatics framework will integrate whole-slide imaging and genomic analysis to generate comprehensive multiscale descriptions of cellular, microenvironmental and regional heterogeneity in human tissues. The volume and complexity of data needed to address this challenge necessitates new approaches to organize, analyze and integrate data over multiple spatial and molecular scales. The imaging component of this project will use image analysis algorithms to generate descriptions of protein expression and DNA content to map pathway activities in billions of cells in whole-slide images, leveraging a novel quantum dot immunohistochemistry (MQDIHC) imaging protocol that enables highly multiplexed measurements of protein expression for unparalleled pathway resolution. Image analysis and statistical machine learning algorithms will be developed to 1.) Mine WSI datasets to precisely describe the spectrum of cellular heterogeneity 2.) Illustrate variations in cellular phenotypes within and across patients 3.) Discover associations between phenotypes and the surrounding local tissue microenvironment and 4.) Relate imaging content to global descriptors like subtype classifications and exome-wide genomic profiles. These data will be integrated through the Pathology Analytic Imaging Standards (PAIS) database, and the proposed algorithms will be implemented to execute in a distributed environment to create a high-throughput tissue processing pipeline. These software tools will be used to engage in scientific studies of glioma brain tumors using human tissues, but are relevant to studies of other diseases including non-cancers. To achieve these goals I propose the following specific aims: Aim 1: Create an active learning system to annotate cellular phenotypes in whole-slide image datasets. One of the greatest challenges in whole-slide imaging is the accurate biological annotation of cells. Inspection of machine-generated annotations is essential to conduct reliable studies, but the scale of data prohibits any meaningful inspection (106-1010 cells). In this aim I will develop a semi-supervised active learning classification system to provide accurate annotation of cells in whole-slide imaging datasets with only very limited training instances. The ability to describe the phenotype of every cell in a WSI dataset given minutes of interactive training will add tremendous scientific value to WSI datasets, enabling WSIs to be interpreted in biologically meaningful contexts. Techniques for "slide ontology" analysis will also be developed, to enable annotated datasets to be mined for cellular phenotype enrichments to elucidate the spectrum of cellular heterogeneity. Aim 2: Develop analytical methods to reveal the influence of tissue microenvironment on cellular phenotypes. Components of the tissue microenvironment like blood vessels and hypoxia are known to influence protein expression in neighboring cells, creating local-scale heterogeneities. In this aim I will develop statistical machine learning methods to quantify these effects, using an image-based model to simulate the exposure of millions of cells to the small molecules (oxygen, signaling molecules) diffused by components of their local microenvironment. Aim 3: Investigate regional intratumoral variations of imaging profiles and genomic subtypes in GBMs. This aim will take advantage of a novel clinical trial conducted at Emory, to investigate intratumoral variations of cellular profiles and genomic subtypes in glioblastoma. This novel surgical technology enables the labeling of resected tissues with precise spatial coordinates, allowing definition of the invading edge, bulk tumor, and necrotic core regions of brain tumors. My previous results show that GBM subtypes are dramatically influenced by cellular and microenvironmental differences in these regions, suggesting that subtypes are not a uniform tumor property. This aim will develop the technology to compare imaging profiles over multiple distinct regions to discover cellular and microenvironmental differences and their relationship to regional genomic profiles and subtypes. The comparative techniques developed in this aim are easily extendable to other important applications, for example comparing cellular profiles across multiple individuals or characterizing cellular and microenvironmental changes at different timepoints in a drug study using animal models.